Community-based Implementation of Hypertension Screening and Telehealth Systems in Kenya (COMPASS)

PROJECT SUMMARY/ABSTRACT
Our main goal is to examine the implementation, effectiveness, and cost-effectiveness of two implementation
strategies for integrating a community health worker (CHW)-facilitated hypertension telehealth intervention into
routine primary health centers operated by Kenya’s Ministry of Health (MoH). Hypertension, a major contributor
to global morbidity and mortality and a key driver of cardiovascular diseases, remains inadequately treated in
Kenya due to multi-level barriers at the health system, clinic, clinician, and patient levels. We previously showed
that CHW-led telehealth interventions, combining CHW home visits and clinician assessment over the phone,
can significantly improve control of hypertension by mitigating patient-level barriers like transportation costs to
clinics. Despite the evidence supporting CHW telehealth, gaps in knowledge about effective implementation
strategies at multiple system levels limit its broader application. This study will assess two approaches aimed at
enhancing uptake, effectiveness, sustainability, and cost-effectiveness of CHW hypertension telehealth in MoH
primary health centers. Guided by the Consolidated Framework for Implementation Research, we have identified
two preliminary sets of implementation strategies: a) core (training, protocol development, MoH leadership
engagement for clinic supervision, and medication supply chain improvements) and b) enhanced (core + plus
implementation champions among clinicians and CHWs, and practice facilitation). The rationale for these
approaches is based on the premise that while core strategies may suffice to address knowledge deficits and
ensure effective implementation initially, additional external facilitation and empowering local champions might
be necessary to reinforce training, increase motivation, iteratively adapt workflows, troubleshoot challenges,
identify ongoing opportunities for improvement, and sustain implementation over time. In Aim 1, we will use
Implementation Mapping with stakeholders from community to health system levels to adapt and refine these
strategies for broader testing. We will attend to adaptation differences between HIV clinic (existing chronic care
infrastructure and electronic medical record (EMR)) and general primary care clinic (current care is generally
episodic, no EMR) settings. In Aim 2, we will conduct a type 2 hybrid implementation-effectiveness cluster
randomized trial across 16 MoH primary health centers and surrounding communities to compare the impact of
core and enhanced strategies on the implementation penetration of CHW telehealth and population-level
hypertension control at 18 months. We will also evaluate sustainment during a 12-month maintenance phase
following cessation of external support for implementation strategies. We will stratify all analyses by HIV status
and sex to understand the role of these factors in implementation and effectiveness. Lastly, Aim 3 will measure
cost and determine the cost-effectiveness of these strategies using an established individual-based hypertension
model. This study will generate robust evidence for the most effective and cost-effective strategies for
implementing CHW-based hypertension treatment, improving BP control and reducing CVD at a population level.

Public health relevance
PUBLIC HEALTH RELEVANCE Hypertension, a major risk factor for cardiovascular diseases, is often underdiagnosed and poorly controlled in Kenya. Scalable community health worker (CHW) approaches that achieve high population-level coverage of hypertension diagnosis and treatment will have a large impact on reducing cardiovascular disease. A detailed understanding of the implementation strategies needed to implement evidence-based CHW hypertension interventions, their mechanisms, and cost-effectiveness will influence public health policy for hypertension treatment and will have broader implications for implementation of evidence-based interventions within public health systems in Africa.